Role of mitochondrial dysfunction in hyperoxia-induced pulmonary vascular endothelial injury

More than 250,000 veterans are placed on mechanical ventilation annually. These patients often require high
fractions of oxygen (hyperoxia) which significantly exacerbates the injury that triggered mechanical ventilation
initially. Pulmonary endothelial cells (PECs) are particularly sensitive to hyperoxia, exhibiting increased
production rates of mitochondrially-derived reactive oxygen species (mtROS), mitochondrial (mt) dysfunction,
pulmonary edema and ultimately increased morbidity/mortality in critically ill patients, but mechanisms are
incompletely understood. Cells adapt to stress by increasing both mitochondrial fission and fusion. Our data
identify for the first time hyperoxia-enhanced mt-fragmentation in PECs, and decreased expression of mt-
fusion and increased expression of mt-fission promoting proteins which underlie the increased mt-
fragmentation. In addition, we show that mitochondrial targeted endonuclease repair protein (mt-ENDO-III)
protects from hyperoxic PEC loss. Finally, we have demonstrated that inhaled 2% hydrogen gas (H2) can
protect against hyperoxia-induced lung injury, and that this protection can be identified by single photon
emission computed tomography (SPECT) imaging. The molecular basis of hyperoxia-associated mt-
fragmentation and subsequent pulmonary microvascular permeability is the focus of this proposal.
Our hypothesis is that hyperoxia-induced pulmonary edema results from mtDNA damage which signals a shift
to pro-fission protein expression and mt-fragmentation, leading to increased microvascular permeability and
edema. Furthermore, we believe that 2% H2 in atmospheric gases will counteract hyperoxia-evoked
pulmonary edema with diminished mtDNA damage and mt-fragmentation. Using novel tools including Dendra-
2 mice, which express a fluorescent protein targeted to the mitochondrial membrane in endothelial cells to
quantify mt-fragmentation in intact tissue, recombinant adeno- and lentivirus, siRNA, unique genetically
modified rodents, vertical experimental designs from cultured cells to intact animals and human tissue, our
work will determine mechanisms linking hyperoxia-induced mtDNA damage, mt-fragmentation and pulmonary
edema. Specific Aims: 1) To determine if hyperoxia-induced pulmonary endothelial mtDNA damage modifies
expression/activation ratios of specific mt-fission and fusion proteins, thereby enhancing mt-fragmentation, and
increasing microvascular permeability. We will use mt-ENDO-III to repair mtDNA damage in cultured PECs and
in vivo and measure hyperoxia-induced changes in pro-fission or fusion protein expression, mt-fragmentation,
mt-function, monolayer transendothelial electrical resistance (TEER) or filtration coefficient (Kf) as
measures of endothelial permeability. 2) To test if pulmonary endothelial mt-fragmentation, independent of
mtDNA damage, increases microvascular permeability. Using genetically modified rodents, siRNA and
overexpression of pro-fission or fusion protein in cultured PECs and in vivo, we will measure pulmonary
endothelial mt-fragmentation, mt-function, and Kf in intact lungs or TEER in cultured PECs. 3) To determine if
(i) H2 protects from hyperoxia-induced mtDNA damage, increased mt-fragmentation, or increased
microvascular permeability, and (ii) SPECT imaging can identify protection secondary to limited mtDNA
damage, diminished mt-fragmentation, or diminished microvascular permeability in vivo. In this translational
aim, we will assess the effect of 2% H2 on mtDNA integrity, shifts in pro-fission/fusion proteins, and mt-
fragmentation. Genetic manipulations of fission/fusion proteins or ENDO-III will be employed to modify mt-
fragmentation, and in vivo SPECT imaging markers of death or oxidoreductive state will identify clinically
relevant endpoints associated with changes in pulmonary endothelial mt-fragmentation. Key results will be
confirmed in human tissue. This work will provide critical new information about the role of mitochondrial
damage in mediating hyperoxia-induced changes in pulmonary microvascular permeability and is expected to
lead to mechanism-based approaches to the prevention and treatment of hyperoxia-induced lung disease.

Public health relevance
Breathing high concentrations of oxygen causes leakage of fluid into the lung airspaces and diminishes the lung’s capacity to oxygenate the blood. Our new data supports critical involvement of the engines of energy production (mitochondria) in the cells lining the blood vessels of the lungs in this injury response. Using novel tools that facilitate quantification of the structure and function of the mitochondria in the vessel lining cells, we will examine the role of these energy production sites in the leakage response of lungs exposed to a high oxygen environment, such as occurs in patients requiring mechanical ventilation. Factors which increase the risk of acute lung injury are alcohol abuse, obesity and chronic lung disease requiring oxygen, all conditions which are more common in veterans than the population in general. Therefore, these studies are of particular importance to veterans.